Leadership and Administrative Core

REVISED ABSTRACT
The Resource Center for Alzheimer’s and Dementia Research in Asian and Pacific Americans (RCASIA) has missions of 1) increasing early career scientists in AD/ADRD-related Behavioral, Social, and Economic Research biomedical research through innovative models of mentoring and community interaction; 2) advancing the rigor and impact of AD/ADRD pilot studies in older APAs through Common Data Elements and data-sharing; 3) serving as a national resource for linguistically/culturally tested and validated tools to assess cognition, function, and AD/ADRD care in APA populations. The Leadership and Administrative Core (LAC) – led by former traditional RCMAR MPIs William Hu, MD, PhD (contact PI) and Bei Wu, PhD – will oversee all administrative tasks including communication and coordination with NIA, RCMAR Coordinating Centers, and affiliated institutions (including NIH-funded APA health-related centers and Alzheimer’s Disease Research Centers). The LAC will provide timely set-up of subcontracts and payments associated with Scientist pilot projects; ensure that each project adheres to the Behavioral, Social, and Economic domains and the theme of People, Culture, Place, and Time; convene the Executive Committee and the External Advisory Committee; review the implementation of Common Data Elements and data-sharing practices; recruit former RCMAR/RCASIA Scientists as consultants in Pods; and evaluate – in collaboration with REC, Cores, and EAC – the effectiveness of the novel Pod/Team mentoring model. The LAC will continue to build long-lasting relationships with RCASIA parent/affiliated institutions, partner studies (New Jersey Population Cohort Study, Rutgers-Stanford Chinese Older Adult Study, planned New Jersey cohort for Mediators of Atherosclerosis of South Asians living in America), mentors, and EAC. Finally, the LAC will monitor faculty-staff, mentor-mentee, and other working relationships to provide first level conflict resolution; bring to the attention of ExC and EAC challenges related to Scientists or RCASIA programs; and revise Pod/Team and other programmatic designs as needed in consultation with ExC, EAC, and NIA.